Characterizing Host-Virus Interactions in a New HIV Model Organism

PROJECT SUMMARY
HIV remains the most consequential zoonosis of the last century, with 36 million fatalities and another 37 million
infected. Even today, almost 2,000 people per day die of HIV/AIDS globally. Medications are reducing the effects
of HIV on the human body and transmission of the virus to others. However, forty years into the HIV/AIDS
pandemic, there are still no vaccines or cures. One hindrance to the development of HIV vaccines and cures
has been the lack of an effective animal model organism. Macaques were thoughtfully developed as an animal
model in the 1980s and remain the main HIV model today. However, there are well-known problems with this
model, with the most significant problem being that SHIVs can only be made to contain about 30% of the HIV-1
genome (essentially, just Env). Here, we describe a new animal model for HIV infection. The overarching goal
of this grant is to design and test physiologically-relevant transmitted/founder (T/F) HIV-1 strains for this new
model species. We examine and optimize the ability of these viruses to bind to CCR5 and RanBP2 host factors
in the new model species, and study how the virus is evading restriction factors in this species. All newly
developed viruses will then be assayed for their sensitivity to neutralization by HIV-1 antibodies. Taken together,
we will learn about the molecular underpinnings of HIV host switching, and at the same time the viruses we
design in this proposal will become a vital tool for HIV-1 research. This new animal model will serve as an exciting
new model system in which to study all aspects of HIV-1 biology and immunity.

Public health relevance
PROJECT NARRATIVE Forty years after the onset of the HIV/AIDS pandemic, still more than 2,000 people per day die of HIV globally. The virus is 100% fatal and, while there are medications that improve and prolong life, there are no cures and no vaccines. We are developing a new model organism that will transform research on the transmission of HIV- 1 and serve as a model for HIV-1 vaccine and cure development.